Exploiting a multiplex HTS assay to identify novel boron-based inhibitors of mycobacterial class II aminoacyl-tRNA synthetases

In 2020 alone, there were 10 million cases and 1.5 million deaths worldwide attributable to Mycobacterium
tuberculosis (Mtb) infection. The emergence of strains resistant to isoniazid and rifampicin – the two most
effective first-line drugs used for treatment – is of great concern. Therefore, there is a pressing need for discovery
of novel inhibitory molecules that are effective against Mtb.
To address this global health threat, our laboratories at the University of Central Florida, in collaboration with
AN2Therapeutics (formerly Anacor Pharmaceuticals), aim to develop novel boron-containing antibiotics targeting
Mtb. In recent years, boron chemistry has proven to be remarkably useful for generating novel lead compounds
and commercial drugs for important diseases, especially in the antimicrobial and antiparasitic space.
Aminoacyl-tRNA synthetases (aaRSs) are efficacious targets due to their essential role in protein synthesis.
aaRSs form the aminoacyl-tRNA (aa-tRNA) used by ribosomes to decode mRNA. Pioneering work at
AN2Therapeutics led to the development of a class of boron-containing compounds (BCCs) that inhibit the
LeuRS from various pathogens. These compounds include the FDA-approved drug tavaborole, two clinically-
relevant inhibitors Epetraborole and Ganfeborole (GSK656), and a candidate drug for African sleeping sickness,
Acoziborole. These BCCs utilize a tRNA trapping mechanism, involving a BCC-tRNA adduct bound to the
enzyme, which ultimately blocks LeuRS activity and protein synthesis.
To overcome the limitations of traditional approaches, we have developed an innovative continuous multiplexed
high-throughput screening assay to target up to four aaRSs simultaneously. This approach enables the
development of multi-target drugs capable of inhibiting multiple enzymes. Such inhibitors hold great promise in
circumventing emerging drug resistance phenotypes, a major challenge in tuberculosis (TB) treatment. Our
specific aims include:
Primary screening of the AN2Therapeutics BCC library using 1) a multi-aaRS high-throughput assay
and 2) an Mtb whole-cell assay. This approach delves into the unexplored potential of class II aaRSs from Mtb
as drug targets. Effectiveness of hits will be assessed against live Mtb, and hits will be counterscreened against
human cytoplasmic and mitochondrial aaRSs to allow triage of compounds with insufficient species specificity.
Microbiological and mechanistic characterization of HTS hits. Top hits will be prioritized based on their
low cytotoxicity towards human cells and minimal resistance frequencies in Mtb. Sequencing analysis will help
identify resistance mechanisms and confirm drug targets. The potency of hit compounds will be assessed in
dormant and intramacrophage Mtb assays, reflecting the challenging conditions encountered during TB infection.
Additionally, their activity against various Mycobacterium species and multidrug-resistant Mtb strains will be
evaluated to ensure broad-spectrum effectiveness.

Public health relevance
Every year, the global incidence of tuberculosis reaches a staggering 10 million cases, resulting in the loss of 1.5 million lives. In this proposal, our objective is to develop boron-containing antibiotics by employing a multi- target assay that focuses on four vital components of the protein synthesis machinery found in Mycobacterium tuberculosis. This approach paves the way for development of multitarget drugs capable of inhibiting multiple enzymes, offering great promise in reducing emerging drug resistances during tuberculosis treatment.